CLINICAL EVALUATION OF NEW INTERVENTION AGENTS

We and others have demonstrated the role of gastrin releasing peptides (GRP) as an autocrine growth factor, and the weight of this evidence is consistent with GRP playing an important role in early cancer formation. We have evaluated the use of a neutralizing monoclonal antibody to block the effect of this growth factor in patients with advanced small cell lung cancer. This treatment is associated with no demonstrable toxicity, but only one patient had a significant anti-tumor response. Based on this experience, we proposed to evaluate a new class of GRP antagonists that are synthetic peptides. This class of molecules may have better properties such as bioavailability and affinity than monoclonal antibodies. These molecules might also be tagged with a radioisotope to permit exact pharmacologic analysis. Synthetic peptide growth factor antagonists may be very useful for delivery as intervention agents, and we proposed to evaluate that possibility. This effort would be a model for the type of rational intervention agent research that the BPRB staff will conduct. Ongoing efforts have included continuation of the Phase II monoclonal antibody trial with the NCI-Navy Medical Oncology Branch. BPRB staff is helping to produce a new preparation of the pharmaceutical grade antibody so the Phase II trial can be completed. Other approaches to blocking GRP dependent growth stimulation are also being developed using either amidating enzyme inhibitors or signal transduction inhibitors. GRP is a molecule that serves as an excellent model of a neuropeptide effector that may be important as a mediator of tumor promotion dynamics in certain epithelium; as such it comprises an attractive target for intervention research.